PANK Activators for the treatment of pantothenate kinase-associated neurodegeneration

SUMMARY
Pantothenate kinase-associated neurodegeneration, PKAN, is a rare progressive
neurodegenerative disorder associated with iron accumulation in the brain. The disease causes
early immobility and often death by early adulthood. PKAN is caused by mutations in one of four
human pantothenate kinase genes, PANK2 gene, which encodes a mitochondrial pantothenate
kinase. Consistent with the clinical presentation of PKAN in humans, cell biological analyses from
patient-derived cells as well as phenotypic characterization of mouse models of PKAN have
demonstrated that the loss of PANK2 activity results in major metabolic, cellular and physiological
defects. To date, no specific or established therapy exists for PKAN with most treatments directed
towards managing symptoms and to slow disease progression. We hypothesize that activation of
the human PANK3 (hPANK3) enzyme would result in stimulation of CoA production in PANK2
mutated cells and would represent an ideal treatment of PKAN. Chemical screening and
subsequent medicinal chemistry optimization (SAR) of the lead chemotype identified 9 human
PANK3 activators (VTAC1-9) that strongly activate hPANK3 with AC50 values in the nM range.
These compounds do not affect the activity of human PANK1 or PANK2, show no toxicity against
four human cell lines and one primary human cell, and have desirable functionality and solubility
properties. Pharmacokinetics studies in mice with the early leads VTAC1 and VTAC2
demonstrated both plasma and brain exposure, excellent t½, and no apparent toxicity. Together
these data indicate that these compounds are ideal candidates for the development of an effective
and safe PKAN therapy. The goal of the parent grant and proposed research is to conduct
detailed characterization of active VTACs and a library of their analogs to identify late leads
that could be advanced towards future clinical development. Towards this end, we will
pursue the following three specific aims. In Aim 1, we will complete current SAR on this family
compounds by characterizing the biochemical activity, selectivity and physico-chemical properties
of an already synthesized 29 analogs and an additional 200 compounds to be evaluated on an
iterative basis. In Aim 2, we will conduct cell-based assays to identify compounds with excellent
in vitro therapeutic index and can restore biological activity in pank2-deficient cells. In Aim 3, we
will conduct ADME and PK analyses and evaluate the in vivo efficacy of VTAC1 and VTAC2 and
new leads from Aim 1 in pank2-/- mice and SynCrepank1fl/flpank2fl/fl mice by monitoring important
PKAN biological metrics including activation of the CoA metabolic pathway, iron homeostasis,
mitochondrial metabolism, and rescue of PKAN-like phenotypes. The success of these studies
will set the stage for future clinical evaluation of a lead activator of hPANK3 as a possible effective
and safe treatment for PKAN.

Public health relevance
Administrative Supplement Request for NIH Grant 1R43NS127740-01A1 Principal Investigator (PI): Jessica Regan, PhD Scientific Director Virtus Therapeutics Corporation 93 Shennecossett Rd, Groton CT, 06340 Phone: (570) 903-5378 Email: [email] Grant Title: PANK Activators for the treatment of pantothenate kinase-associated neurodegeneration Grant Number: 1R43NS127740 Funding Opportunity Announcement (FOA) Number: PA-21-345 Budget Period: 09/15/2023 -08/31/2024 Project Period: 09/15/2023 -08/31/2025 Amount of Supplement Request: $99,000 1. Introduction This request is for an administrative supplement to NIH grant 1R43NS127740, titled “PANK Activators for the treatment of pantothenate kinase-associated neurodegeneration” due to unforeseen increases in animal costs that were not anticipated at the time of the original budget submission. The supplement will ensure the continuation and successful completion of the proposed research. 2. Justification Most of the funds from the initial reward designated for animals have been used to breed, maintain, and perform drug treatments using the whole-body pank2-/- mouse model of PKAN. There is no observable phenotype associated with the whole-body pank2-/- mouse model, therefore, we initiated breeding of SynCrepank1fl/flpank2fl/fl mice, which display symptoms associated with PKAN including weight loss, locomotor disfunction, and early death. Whole-body pank2-/- mouse model of PKAN. • We received pank2-/+ heterozygous mice from the Hayflick lab on 01/26/2022 and began breeding them to obtain pank2-/- homozygous progeny, at a rate of 25%. A total of 191 homozygous pank2-/- animals were obtained throughout one year of breeding. • We did not see upregulation or downregulation of genes as previously reported for this model1. The breeding pairs we received were at the end of their backcross cycle, therefore it was possible that the RTqPCR results were due to the late cycle, therefore backcrosses were recommended. Heterozygous pank2+/- mice were bred with C57B6 mice across three generations. After the third generation, three males were selected, and their sperm cryopreserved. • Homozygous pank2-/- mice were treated with vehicle, VTAC-1 and VTAC-2, as well as PZ2891 as a control, for 14 days. Brains were removed and dissected into four parts: the Globus Pallidus (GP), the Substantia Nigra (SN), olfactory bulb, and cerebellum. Total RNA from collected tissues were extracted using phenol/chloroform method with QIAzol and used in qRT-PCR to determine transcript levels of genes relating to CoA biosynthesis. Additionally, CoA levels in each region will be quantified to confirm activation of CoA biosynthesis. Analysis of gene transcript and CoA levels is ongoing. SynCrepank1fl/flpank2fl/fl mouse model of PKAN • As stated in the alternative approach section in aim 3 of the parent grant, an additional mouse model of PKAN was originally reported by the team of Dr. Jackowski at St. Jude and has subsequently been used by BridgeBio to validate efficacy of PKAN therapeutic, BBP-671. This model has been used to study PKAN as the mice exhibit symptoms similar to individuals diagnosed with PKAN including weight loss, locomotor impairment and early death2. • We received pank1fl/fl sperm and pank2-/- embryos and began mouse breeding in March 2023. Initial genotyping revealed three pank2 genotypes and one pank1 genotype: pank2fl/+, pank2fl/fl, and pank2fl/-, and pank1fl/+. Pank1fl/+ mice were bred with mice expressing each of the three pank2 genotypes to generate 52 pank1fl/+/pank2fl/+ mice and one pank1fl/+/pank2fl/fl mouse. • SynCre hemizygous mice were obtained from Jackson labs and were bred with mice expressing genotypes Pank1fl/fl/Pank2fl/+ and Pank1fl/+/Pank2fl/fl to generate Pank1fl/fl/Pank2fl/+SynCre+ and Pank1fl/+/Pank2fl/flSynCre+. These mice will be bred with Pank1fl/fl/Pank2fl/fl to generate the target mice expressing SynCrepank1fl/flpank2fl/+ and SynCrepank1fl/+pank2fl/fl genotypes. After each round of breeding, mice will be genotyped from nail clippings to select for SynCrepank1fl/flpank2fl/fl mice. As SynCrepank1fl/flpank2fl/fl mice are generated, treatments will begin to maintain consistency of mouse age between treatments. Sperm from key intermediate stages will be frozen and stored for future breeding. We expect to have SynCrepank1fl/flpank2fl/fl mice ready for the proposed studies by the end of 2024. See diagram for breeding details. • Groups of mice consisting of 5 females and 5 males will be housed under 12h light cycles with free access to chow and water and dosed with 10 mg/kg (of the front-runner VTAC compounds and PZ-2891 and BBP-671 as controls) via oral gavage once daily for 14 days and monitored daily for their weight and activity. Following treatment, mice symptoms will be monitored including changes in weight and motor function. The brains of mice which show symptomatic improvement will be removed and dissected in regions containing the Globus Pallidus (GP), Substantia Nigra (SN), olfactory bulb, and cerebellum. Total RNA will be collected from tissues and extracted using the phenol/chloroform method with QIAzol and used in qRT-PCR analysis to quantify mRNA levels of the CoA biosynthetic genes and key markers of iron and dopamine dyshomeostasis. CoA levels in the brain will be measured by LC/MS-MS and intracellular iron concentrations will be quantified by ICPMS (Inductively-Couple Plasma Mass Spectroscopy). • Success will be determined by the ability of the VTACs to improve symptoms associated with PKAN, extend survival, restore CoA levels, and correct of iron and dopamine dyshomeostasis markers. 3. Description of Costs • Strain reanimation (IVF): $1100/service • Strain reanimation (embryos): $750/derivation • Housing cost per diem: $1.27 per cage • Cryopreservation: $750 per sperm • Tissue collection: $72/hour • Mouse genotyping: $10 per mouse 4. Impact on Research The increased costs have put the project at risk of not being able to achieve its specific aims. Without this supplement, we will not be able to continue breeding SynCrepank1fl/flpank2fl/fl mice for treatment with VTACs. The requested funds are essential for maintaining the integrity and scope of the research as originally proposed. 5. Budget Item Cost Housing and Care $59,000 Tissue collection/data analysis $40,000 Total Supplement Request $99,000 6. Timeline The additional funds are needed immediately to cover the increased costs. Upon approval, we anticipate no delays in the project timeline and expect to complete the project as originally scheduled by 08/31/2025. 7. PI Assurance I assure that the requested supplemental funds will be used solely for the purpose of covering the costs associated with studies involving the use mouse models of PKAN conducted under the Sponsored Research Agreement with Dr. Ben Mamoun at Yale and performed at the Yale Animal Core Facility. No other aspects of the project will be altered. 8. Signatures Principal Investigator: Jessica Regan June 17, 2024 Authorized Institutional Official: Choukri Ben Mamoun Founder and Signing Official Choukri Ben Mamoun July 21, 2024 Summary of parent grant • Aim 1: Characterize PTZ analogs for in vitro activity and selectivity o Proposed ▪ Nine VTACs have been characterized for modulation of human PANK3 activity. Here, we will extend analysis to an additional 29 analogs to identify top compounds based on their modulation of PANK activity. o Achieved ▪ In addition to the original nine VTACs, five compounds were confirmed to specifically activate human PANK3 using an ATPase assay with purified hPANK3 enzyme. • Aim 2: Further examine the safety of the compounds and evaluate their in vitro cell biological activity in PANK2-deficient cells. o Proposed ▪ Extend analyses of hPANK3 activation and toxicity profile of the 14 VTACs and conduct cell-based assays to identify those that restore biological activity in PANK2-deficient cells and select ideal candidates for animal models. o Achieved ▪ Further analyses are being conducted to examine the safety of the initial 9 VTACs as well as the addition 5 compounds identified in Aim 1. The in vitro cytotoxicity of each of these compounds is being tested on four human cell lines (HeLa, HepG2, HEK293, and HCT116) and one primary cell line (HFF-BJ). So far, the initial 9 VTACs have been tested in the four human cell lines at concentrations up to 100 µM and their toxicity was compared to PZ-2891. The 9 VTACs tested had similar cytoxicity levels compared to PZ- 2891 in each of the four cell lines, with the majority of the 9 VTACs having IC50’s >100 µM. Cytotoxicity studies with the remaining 5 compounds in these four human cell lines, as well as all 14 compounds in the primary cell line are ongoing. ▪ Further evaluation of in vitro cell biological activity of the VTACs are being conducted to select lead compounds for clinical development. Cell-based assays are ongoing to identify those compounds which restore biological activity in PANK2-deficient cells. Treatment of PANK+/+-CoA-Luc and PANK/--CoA-Luc cells with each of the 14 VTACs is in progress. Cells will be cultured in plates and treated with different doses of the activators ranging between 1 nM and 1μM or vehicle (media or DMSO) for 24h, with PZ- 2891 as a control. Analysis of relative mRNA levels of CoA biosynthetic genes and other related genes was conducted in PKAN patient cell lines compared to healthy patient cell lines as well as HFF wild-type and pank2 knock-out cell lines to identify genes whose expression levels are altered by PANK2 deficiency. These studies demonstrated reduced expression of Transferrin Receptor (TFRC) similar to that of PANK2 in PKAN patient cell lines as well as pank2 knock-out cell lines. Based on these studies, qRTPCR will be performed to determine if the 14 VTACs can restore expression of TFRC. MTT colorimetric assay is used to measure cell metabolic activity in untreated and treated PKAN and control cells following conversion of the tetrazolium dye MTT into its insoluble formazan. The MTT assay has so far been completed with the initial 9 VTAC compounds. • Aim 3: Evaluate the in vivo efficacy of lead VTAC activators in mouse models of PKAN. o Proposed ▪ Initial PK and CNS exposure studies in mice have so far identified VTAC-1 and VTAC-2 as leads for further evaluation in the mouse model of PKAN. We will first evaluate these 2 compounds as well as new leads that meet rigorous criteria for testing in animals for their in vivo pharmacokinetic and safety. Selected compounds will then be evaluated for in vivo efficacy in pank2-/- mice by monitoring important PKAN biological metrics including activation of the CoA metabolic pathway, iron homeostasis, mitochondrial metabolism, and rescue of PKAN-like phenotypes. o Achieved ▪ Whole-body pank2-/- mouse model of PKAN were bred from pank2-/+ heterozygous mice at a rate of 25%. ▪ Groups of 5 females and 5 males were dosed with 0, 10, and 30 mg/kg of VTAC-1 and VTAC-2, as well as PZ-2891 as a control. The brain of each mouse was removed and dissected in regions containing the Globus Pallidus (GP), Substantia Nigra (SN), olfactory bulb, and cerebellum. RNA from the collected tissues was extracted and qRT-PCR performed to measure levels of key CoA biosynthetic genes. CoA levels in each brain region will be quantified by LC/MS-MS. ▪ Samples from untreated PKAN knock-out and wild-type male and female mice were sent for LC-MS and metabolomics to quantify RNA transcript levels. RTqPCR analysis on tissues has been completed, however, the expected upregulation or downregulation of key genes as described by the Hayflick lab were not observed. Preliminary analyses indicate a slight increase in CoA levels in the brain upon treatment with VTAC-2 in wild- type mice compared to vehicle treatment. Further analysis of CoA levels is ongoing and we expect results to be available by the end of 2024. (1) Jeong, S. Y.; Hogarth, P.; Placzek, A.; Gregory, A. M.; Fox, R.; Zhen, D.; Hamada, J.; van der Zwaag, M.; Lambrechts, R.; Jin, H.; et al. 4'-Phosphopantetheine corrects CoA, iron, and dopamine metabolic defects in mammalian models of PKAN. EMBO Mol Med 2019, 11 (12), e10489. DOI: 10.15252/emmm.201910489. (2) Sharma, L. K.; Subramanian, C.; Yun, M. K.; Frank, M. W.; White, S. W.; Rock, C. O.; Lee, R. E.; Jackowski, S. A therapeutic approach to pantothenate kinase associated neurodegeneration. Nat Commun 2018, 9 (1), 4399. DOI: 10.1038/s41467-018-06703-2.